Extension of the World Trade Center Health Registry

ABSTRACT
The World Trade Center (WTC) Health Registry, the largest post-disaster registry in U.S. history, is among the
world’s longest running as it continues to track long-term health impacts of the 9/11 disaster among a diverse
cohort of over 71,000 persons who performed 9/11-related rescue/recovery work (responders), or who lived,
worked or attended school in lower Manhattan on 9/11/2001 (survivors). The Registry’s 142 peer-review
publications to-date contribute substantially to the literature on 9/11 physical and mental health outcomes and
gaps in care and inform 9/11 healthcare policy and clinical practice. The Registry also conducts extensive
outreach to refer enrollees to the WTC Health Program (WTCHP) and provides de-identified survey data and
recruitment services for 9/11-related research by independent or collaborative external researchers. This
renewal will enable the Registry to extend its epidemiological research and surveillance 24 years post- 9/11 via
follow-up health surveys and in-depth studies, including cancer and mortality assessments and in-depth
studies with WTCHP entities to identify potential emerging health conditions. We propose 5 specific aims:
(1) Maintain the Registry as a public health resource to allow health professionals to track and investigate
possible trends in illness and recovery (i.e., maintain updated contact information for enrollees, keep them
engaged); (2) Expand knowledge about long-term health effects of 9/11 by facilitating medical, public health,
emergency preparedness or other research relevant to the WTC Health Program with emphasis on impacts to
the WTC survivor cohort (i.e., continue matches to vital records, cancer registries and hospitalization data;
extend cancer/mortality assessments 20 years post-9/11; conduct a Wave 6 survey to ascertain cohort health
status 23-24 years after 9/11; conduct qualitative research to better understand persistence of 9/11 conditions
and their mitigation; assess the contribution of 9/11 exposure and other risk factors to the course of health
conditions, functional impairment, age-related conditions, and unmet healthcare needs); (3): Conduct
community activities to respond to the physical and mental health concerns and specific healthcare needs of
enrollees and others exposed to 9/11 (i.e., disseminate Registry findings and recommendations to enrollees,
the public, and WTCHP leadership via video, social media, e-newsletters, website; provide data and other
resources to enrollees and the public; continue health promotion activities); (4): Maintain the 9/11 Treatment
Referral Program to help enrollees and others find care for 9/11-related health problems (i.e., inform enrollees
of 9/11-related services, conduct outreach to assist them in applying to the WTCHP, including those with
specific conditions or unmet care needs); and (5): Collaborate with WTCHP entities to explore surveillance
signals and treatment outcomes including 9/11 linkage with uncommon health conditions (e.g., autoimmune,
neurological disease), treatment outcomes for selected 9/11 conditions, and conducting activities to address
emerging WTCHP priorities regarding health and wellness issues..

Public health relevance
PROJECT NARRATIVE The World Trade Center Health Registry contributes to public health by identifying the long-term physical and mental health effects and health care needs of persons directly affected by the World Trade Center disaster. The Registry shares its health findings and recommendations with enrollees, the public, health care providers, scientists, policy makers, and the World Trade Center Health Program. The Registry also provides information about 9/11-related services and offers treatment referral and health promotion opportunities for enrollees.